Exposure to Insecticides and Child Growth and Pubertal Development in a South African Population Exposed Through Indoor Residual Spraying

7. PROJECT SUMMARY/ABSTRACT
Since 1980, the global prevalence of overweight and obesity increased by 27.5% in adults and by 47.1% in
children. Although rates appear to have tapered off over recent years in many developed countries, steady
increases continue to be reported in developing countries, most particularly in Africa. Between 1990 and 2010,
the number of overweight and obese children doubled in Africa and in 2017, the highest prevalence of
overweight and obesity among young children was found in the Southern Africa U.N region. In South Africa’s
Vhembe district, the prevalence of childhood overweight and obesity increased by a factor of 2.7 between 2008
and 2015, reaching 40%. Concomitantly, earlier onset of puberty has been observed globally and it has been
suggested that increasing trends in obesity prevalence may play a role. Although changes in diet and physical
activity likely influence these trends, growing evidence suggests that exposure to chemicals that disrupt
endocrine function may be a factor.
A total of 88 countries practice Indoor Residual Spraying (IRS), the use insecticides on the interior walls of
residences to control malaria, resulting in high exposure to endocrine-disrupting chemicals such as
dichlorodiphenyl trichloroethane (DDT) and pyrethroids. DDT, a known environmental estrogen, increases
body fat and advances puberty in female rodents while DDT’s breakdown product dichlorodiphenyl
dichloroethylene (DDE), an antiandrogen, delays puberty in males. Few human studies have investigated
associations between DDT exposure and body composition or pubertal onset but studies of DDE found
relations with delayed puberty in boys and our preliminary studies suggest that DDE is obesogenic in South
African girls. Animal studies show that pyrethroids, which are androgenic, delay puberty onset in females and
accelerate puberty in males but this question has only been studied by one group in China.
To our knowledge, no study has investigated the impact of exposure to DDT or pyrethroids on body
composition, pubertal onset or endocrine function in peripubertal African children. We propose to address
these important knowledge gaps by extending a unique birth cohort study of rural South African children with
extensive data on health, exposure and confounders, rich research infrastructure and strong community
networks. We aim to identify the levels and determinants of exposure to DDT/E and pyrethroids among
children aged 7 to 10 and determine whether pre- and postnatal exposure to these insecticides is associated
with: 1) altered body composition, 2) puberty timing and tempo, and 3) hormone levels.
This study will provide policy-makers with data to better understand the determinants of the dramatic rise in
obesity and the acceleration of puberty in South Africa and other developing countries. It will also provide
essential information on the potential unintended consequences of IRS to malaria-endemic countries and
international bodies so that they can determine the safest and most sustainable methods to control malaria.

Public health relevance
8. PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE STATEMENT The prevalence of overweight and obesity has dramatically increased in developing countries such as South Africa while age at puberty onset has been decreasing. Evidence suggests that exposure to insecticide that interfere with endocrine function may play a role. We propose to evaluate whether exposure to DDT and pyrethroids, which are commonly used as part of Indoor Residual Spraying programs in developing countries is associated with body composition and timing and tempo of puberty in a birth cohort of 752 rural South African children.